Investigating the role of endothelial Gimap5 in maintaining liver homeostasis

Project Summary/Abstract
Liver disease is the 10th leading cause of mortality annually. Although most of these deaths are related to
cirrhosis from known causes, an estimated 10-30% of individuals have liver disease of unknown etiology.
Whole exome sequencing (WES) can provide an actionable diagnosis in 10-30% of these patients. The
Vilarinho Laboratory recently used WES to diagnose a cohort of patients with non-cirrhotic portal hypertension
with loss of function mutations in the gene GIMAP5. GIMAP5 is a small GTPase that has previously been
implicated in immune cell development but had never been associated with liver disease. Using a mouse
model of Gimap5 loss of function, we determined that liver sinusoidal endothelial cells (LSECs) capillarize and
lose their organotypic features in GIMAP5-mediated disease. In my preliminary work I performed pseudotime
analysis on single cell RNA sequencing data to determine that LSECs dedifferentiate into capillarized
endothelial cells. Endothelial capillarization is a pathogenic process that occurs in numerous liver disorders
and involves loss of fenestrae and development of a basement membrane. Additionally, in order to better
understand the organ wide dysfunction caused by endothelial capillarization, I performed confocal microscopy
to evaluate zonation in hepatocytes. This demonstrated severe disruption of normal metabolic zonation of the
liver. Collectively, these findings suggest that GIMAP5-mediated liver disease is an LSEC-intrinsic disease
process that consequently effects hepatocyte zonation and regulates liver homeostasis. I hypothesize that
Gimap5 is critical to maintaining LSEC identity and subsequently hepatocyte zonation and function. My first
aim is to determine the role of Gimap5 in LSECs. I have created a novel mouse model, that uses a Cre-Lox
system in order to knockout genes within LSECs in an inducible and selective manner. I will use this model to
knockout Gimap5 within LSECs and then evaluate endothelial capillarization as well as organ-wide
dysfunction. I will use a combination of flow cytometry, confocal and electron microscopy to visualize changes
due to this dysfunction. My second aim is to determine the role of endothelial Gimap5 in maintaining
hepatocyte zonation and function. It has been well recognized that endothelial derived Wnt signaling is
necessary for the proper maintenance of hepatocyte metabolic zonation. Preliminary data shows that these
Wnt signals are significantly reduced in Gimap5 loss of function endothelial cells. I will perform single cell RNA
sequencing to investigate transcriptional alterations of hepatocytes in Gimap5 loss of function mice. I will also
isolate mouse hepatocytes from Gimap5 loss of function mice to evaluate alterations in hepatocyte metabolic
activity using functional assays. If successful, this proposal will identify the pathomechanisms behind GIMAP5-
mediated liver disease and potentially elucidate a novel mechanism of endothelial capillarization in other more
common forms of liver disease.

Public health relevance
Project Narrative Liver disease is one of the highest causes of morbidity and mortality in the country, and by studying rare forms of liver disease evidence suggests we can better understand more common forms of disease. GIMAP5 is a protein that when mutated to cause a loss-of-function leads to dysfunction of the cells that compose blood vessels in the liver. By better understanding the mechanisms by which GIMAP5 causes blood vessel dysfunction, we can potentially discover novel treatments for patients with this rare disease as well as for more common forms of liver disease.